Using auxin to understand context-dependent hormone response

Title: Using auxin to understand context-dependent hormone response
Project Summary
Cells constantly integrate a suite of intrinsic and extrinsic information to coordinate their
activities. The suite of stimuli perceived by a cell – the context – can drastically alter the
response to a subsequent stimulus. The plant hormone auxin provides a fascinating example of
this context-dependent response: auxin regulates diverse phenomena from cell expansion to
cell fate specification during all aspects of a plant's life. How the same hormone can elicit such
diverse responses depending on the context is unknown. Here I propose work to discover
genetic factors required for context-depending auxin response. Seedlings of Arabidopsis
thaliana respond oppositely to exogenous auxin when grown in the light versus when grown in
darkness. I hypothesize that auxin triggers distinct genetic pathways in light and darkness.
Using Arabidopsis as a model, I will test this hypothesis first by performing a mutant screen that
will isolate novel factors required for context-dependent and context-independent auxin
signaling. I will subsequently assay how the DNA-binding landscape of AUXIN RESPONSE
FACTOR (ARF) transcriptional effectors compares in light and dark-grown hypocotyls. If ARF
binding varies substantially due to context, I will test whether differences in chromatin
accessibility underlies this variation. If ARF DNA-binding is similar across contexts, then other
factors in complex with the ARFs are likely responsible for modulating auxin response; these will
be investigated using TURBO-ID to identify ARF protein complex components. Finally, I will
perform time course RNA-seq followed by Gene Regulatory Network (GRN) analysis to assess
how the transcriptional response to auxin changes in the light versus in the darkness. Altogether
the mutant screen, ARF DNA-binding profiles, and GRNs will elucidate how context affects the
response to a stimulus and identify important factors in context-dependent signaling that can be
investigated in the future.

Public health relevance
Project Narrative How cells integrate a suite of contextual information to generate a response is a poorly understood but critical question in biology. Elucidating how and why response to a hormone changes according to contextual information will be informative for solving diverse problems, from diseases such as cancer to engineering crops suited to new or changing environments.